NYU-CUNY Prevention Research Center

NYU-CUNY Prevention Research Center Project Summary
For two decades, New York City (NYC) has been at the national forefront of innovative programming and
policy to improve chronic disease prevention and care. However, racial/ethnic and socioeconomic health
disparities have widened and the city's most marginalized groups remain largely disconnected from public
health and healthcare structures. Translation of innovative prevention strategies extending outside the clinical
setting to reduce disparities requires shared goals among multi-sector stakeholders and a process for
implementing, disseminating and adapting evidenced models by a diverse array of public health, clinical and
community partners. The proposed application seeks to expand upon a successful, innovative public-private
partnership between the New York University (NYU) School of Medicine and the City University of New York
School of Public Health (CUNY SPH) to renew the NYU-CUNY Prevention Research Center (PRC) for a third
cycle. Our research and translation agenda focuses on advancing and scaling effective community health
worker (CHW) and other community-clinical linkage intervention models to reduce chronic disease and access
to care disparities among socially disadvantaged populations. Our PRC leverages an extensive network of
public health practice and research collaborations between the two institutions, many of which are performed in
partnership with local and state health agencies, health systems, community organizations and payers. We
have established a robust community-engaged, multi-sector stakeholder platform with expertise in
implementation and systems science, an infrastructure vital to the success of the Center's expanded
translation agenda. Our work thus far has contributed substantively to the growing body of evidence on the
efficacy and effectiveness of CHW and related community-clinical strategies targeting minority and immigrant
communities, as well as low-income public housing residents for cardiovascular disease, hypertension, and
diabetes prevention and management. Our Center has been at the forefront of innovative multi-system
partnerships and models to address social determinants of health. Building on our robust portfolio, the
proposed Core Research Project consists of a public health practice-based research. This initiative will
evaluate the effectiveness of a CHW-facilitated trauma-informed care program spearheaded by the New York
City Department of Health & Mental Hygiene to improve access to care and health outcomes among justice-
involved individuals, advancing translation and dissemination of effective community-clinical linkage strategies
for socially disadvantaged and health disparity populations.

Public health relevance
Project Narrative Established in 2009, the NYU-CUNY Prevention Research Center is seeking a third cycle of funding, with a research and translation agenda focused on advancing and scaling effective community health worker (CHW) and other community-clinical linkage intervention models to improve access to care and reduce chronic disparities among socially disadvantaged populations. This application (1) builds on our established, community-engaged bench of public and private partnerships, (2) expands our institutional commitment and research depth in implementation research and systems science, and (3) introduces a new partnership with the New York City Department of Health and Mental Hygiene to perform a public health practice-based research evaluation of a novel CHW-facilitated trauma-informed intervention to improve the health of justice-involved populations.